Diet-derived oxysterols shape intestinal B cell fate by controlling intracellular cholesterol metabolism

Abstract
B lymphocytes in the gastrointestinal tract are constantly stimulated by commensals microbial antigens. In order to
prevent commensal outgrowth and maintain intestinal homeostasis, B cells need to mount a rapid antibody response
against bacterial antigens.
To achieve this task, the humoral immune system relies on a complex multistep process of B cell proliferation and
selection in the germinal center, which eventually gives rise to either antibody secreting plasma cells or memory B cells.
Intestinal B cells are also exposed to dietary and microbial metabolites during their activation and differentiation, but
how these environmental cues shape B cell fate and antibody response in the gut is poorly understood.
Therefore, elucidating the fundamental mechanisms that intrinsically regulate the fate and function of individual B cell
clones in the gut remains a central question in immunology.
Several lines of evidence indicate that metabolic switches act as intrinsic regulators of germinal center B cell response.
However, how B cells integrate metabolite sensing with germinal center and antibody response remains undefined to
date.
In this application we test the hypothesis that the oxysterol 25-HC, an oxidized form of cholesterol, directly controls
germinal center B cell response through its interaction with the Sterol Response Element Binding Protein 2 (SREBP2).
SREBP2 is a key regulator of intracellular cholesterol homeostasis, and its transcriptional activity in the intestinal
germinal center B cells couples lipid metabolism and B cell differentiation in the intestine. We also hypothesize that
follicular dendritic cells (FDCs), stromal cells which are located in the germinal center, produce 25-HC in response to
dietary cholesterol and microbiome, therefore linking rapidly changing intestinal homeostasis to B cell fate.
Accumulating evidence indicates that 25-HC controls SREBP2 processing, but the implication for this cross talk in B
cells in the gut has not been investigated so far.
Our aims are: 1) To test the hypothesis that SREBP2 activity controls germinal center B cell transcriptional profile and
B cell fate; and 2) To define the environmental and cellular cues that regulate 25-HC niche.
The proposed studies examine a very poorly understood crosstalk between oxidized form of cholesterol, intestinal
metabolism and adaptive immune system activation. It is our expectation that these studies will increase our
understanding of how intestinal metabolism shapes B cell responses and adaptive immunity. Furthermore, these studies
will provide a foundation for better understanding of the relationship between lipid metabolism and differentiation in
immune cells.

Public health relevance
Narrative Intestinal humoral response occurs in an environment exposed to multiple metabolic stimuli, from both diet and commensal bacteria. We identified the transcription factor SREBP2 as a potential key regulator of germinal center response. Oxysterols, oxidized forms of cholesterol, have been shown to control SREBP2 activation and transcription activity. This proposal aims to identify the mechanisms by which SREBP2 shapes germinal center B cell differentiation in antibody-secreting plasma cells and to map oxysterol niche and its extrinsic requirements. Thus, insight into the oxysterols-SREBP2 axis during germinal center B cell differentiation and into the cellular and environmental regulation of oxysterol production, will be generated from this proposal.